Identification of Listeria monocytogenes immune evasion mechanisms

Abstract:
The continued emergence of antibiotic resistance has led to a global health crisis, leading to a predicted 10
million deaths per year by 2050 without significant intervention. Targeting bacterial virulence determinants with
novel antibiotics rather than essential proteins would limit resistance development. We will utilize two powerful
model systems, Listeria monocytogenes infection in the Danio rerio (zebrafish) model, to identify bacterial
virulence factors that will serve as novel targets for antibiotic development. L. monocytogenes is a human and
livestock pathogen that is the causative agent of Listeriosis. Perhaps more importantly, it is also a well-studied,
genetically tractable model pathogen that has been used for decades to dissect novel mechanisms of bacterial
pathogenesis, innate immune activation and cell biology. The zebrafish is a similarly well studied model host
organism with robust genetic tools, high fecundity and translucent larvae that make them ideal models for
infectious disease and innate immunity studies. In this proposal we will identify novel antibiotic targets in L.
monocytogenes using a high-throughput transposon insertion sequencing (TIS) negative selection approach. In
aim 1 we will execute our L. monocytogenes TIS screen in macrophage cell culture, identifying genes that are
required for bacterial invasion, phagosomal escape, and cytosolic survival and replication in a cell autonomous
manner. In aim 2 we will repeat the TIS screen in intact zebrafish larvae, identifying genes required for infection
in vivo. Comparing cell culture essential genes with those identified in vivo will highlight those genes necessary
for infection in the context of an immune system. Finally, to fully exploit the genetic tractability and high
throughput nature of the zebrafish, and to identify bacterial virulence determinants required for defense against
specific components of the host immune response, we will perform TIS in transgenic zebrafish deficient in
components of the phagocyte oxidase complex or the inflammasome complex. Upon completion of these aims
we will have developed and executed a whole genome screen to identify novel virulence factors in L.
monocytogenes required for cell intrinsic virulence, in vivo virulence, and virulence selectively necessary to
combat reactive oxygen species and inflammasome activation. Future studies will expand on these proof of
principle experiments to identify virulence factors required for other aspects of innate immunity (antimicrobial
peptides, nutritional immunity, specific cytokine functions, etc) as well as utilizing the hits identified in our screens
to screen for small molecule inhibitors as novel antibiotics.

Public health relevance
Project Narrative: Antibiotic resistant infections pose a public health crisis requiring new approaches to antibiotic development. In this proposal we will develop and apply genome scale screens to identify virulence factors that can serve as novel antibiotic targets in the human and animal pathogen Listeria monocytogenes. Upon completion of these aims we will have a high value target list for novel antibiotic discovery, will have defined novel virulence factor functions in immune evasion and will have identified potential synergies between antibiotic therapies and protective immune responses.